Developmental Research Program

ABSTRACT
The goal of the Developmental Research Program (DRP) of the Memorial Sloan Kettering Cancer Center
Leukemia SPORE is to provide seed funding for pilot projects that show potential to make meaningful
advances in leukemia prevention, diagnosis, and/or treatment. Supplemented by institutional funds, the DRP
will provide one to two years of funding to talented investigators or research teams from clinical and/or basic
science backgrounds from the MSK community, neighboring institutions, or in support of collaborations with
other Leukemia SPOREs. We will invite candidates annually to submit research proposals for peer-review by
a committee of experts in leukemia and translational cancer research. We will prioritize research proposals that
describe high-risk/high-reward hypothesis-driven work that has the potential to advance new avenues of
leukemia investigation, or proposals that bring together exciting collaborative teams who will address ongoing
problems in the leukemia field using new approaches and technologies. Applicants for DRP funding should
possess an MD and/or PhD degree and should hold independent-investigator status as a faculty member or
clinical researcher/research scientist at their institution. Applicants should have demonstrated a clear
commitment to translational cancer research related to leukemia. The DRP investigators will be considered full
members of the MSK SPORE in Leukemia and will participate ongoing meetings and research seminars
(regular meetings and seminars held by the Leukemia Working Group, Leukemia Disease Management Team,
Center of Hematologic Malignancies Science in Focus) as well as specialized SPORE meetings (annual, multi-
institutional SPORE Retreat; SPORE Seminar Series; monthly progress meetings). The DRP projects will be
monitored by the Executive Committee at monthly progress meetings, and will be reviewed to evaluate
potential to grow into a full SPORE research project in the current or upcoming grant cycle. The DRP
is committed to adhering to and supporting the MSK policies and procedures to promote diversity and
strengthen the participation of women and individuals from underrepresented minorities.

Public health relevance
NARRATIVE The majority of leukemia patients relapse after initial therapies, underscoring the need for improved targeted therapies and better predictors of clinical response. The Developmental Research Program supports innovative pilot projects, technologies and research collaborations that have the potential to improve the diagnosis, prevention, and/or treatment of leukemia.